Understanding the neural markers of incentive salience for alcohol: the role of context in brain-behavior relationships

PROJECT SUMMARY/ABSTRACT
Understanding incentive salience for alcohol cues—a “wanting” of alcohol driven by a strong association
between alcohol-related cues and a reward—is of critical importance for understanding the etiology of alcohol
use disorder (AUD). Enhanced incentive salience for alcohol cues is among the more powerful and immediate
precipitating factors driving alcohol use and, over the longer term, has been implicated in development of AUD.
Thus, understanding incentive salience for alcohol has emerged as a research priority within addiction science.
While studies utilizing fMRI and EEG to investigate incentive salience have consistently identified heightened
incentive salience for alcohol as a neural marker of problem alcohol use, these neuroimaging investigations have
exclusively measured incentive salience devoid of context. Consequently, there is a critical gap in understanding
how this individual-level marker unfolds in real-world settings, where individuals are exposed to a diverse array
of alcohol-related stimuli. Therefore, whether incentive salience, as measured via laboratory neuroimaging
methods, holds genuine relevance to alcohol use behaviors in individuals’ everyday life remains unknown.
The proposed research aims to fill this gap in the literature by leveraging a combined laboratory-ambulatory
study design, in a sample of young adult heavy drinkers. More specifically, we will characterize the brain-behavior
mechanisms of incentive salience driving alcohol use behaviors in everyday life. Here we extend beyond the
laboratory, utilizing not only fMRI and ERP measures of incentive salience but also ambulatory biosensor
technology to capture alcohol use behaviors in real world context. Further, in line with NIAAA’s stated goal to
examine “how alcohol-related neurobiological and behavioral phenotypes interact with the environment to affect
alcohol-related outcomes” (NIAAA Strategic Plan 2017-2021), we will examine how features of everyday drinking
contexts may moderate the relationship between incentive salience and alcohol use levels. To achieve this end,
the proposed study will utilize innovative ambulatory photograph methods to better characterize the physical and
social context of drinking.
As an important step toward a contextually-informed, yet mechanistically precise model for understanding
AUD etiology, the proposed research has multiple critical implications. In the conceptual realm, findings will
inform theoretical models of AUD (e.g., incentive sensitization theory) that may strengthen our understanding of
mechanisms underlying AUD development and maintenance. In the clinical realm, findings will inform
assessment, prevention, and intervention efforts, by refining the understanding of both individual- and contextual-
level risk factors for problem drinking in real-world settings. Finally, in the methodological realm, the proposed
research offers a novel experimental paradigm to alcohol researchers, by leveraging the mechanistic precision
of neuroimaging techniques and the ecological validity of ambulatory momentary assessment.

Public health relevance
PROJECT NARRATIVE Understanding incentive salience for alcohol cues has been long held by researchers to be of critical importance for the understanding of the etiology of alcohol use disorder. In line with the NIAAA’s stated goal to elucidate the interplay between neurobiological and behavioral mechanisms of incentive salience, the proposed research aims to diminish the gap between the world of experimental neuroscience findings in incentive salience and its behavioral manifestations in everyday life. Further, the proposed study will explore drinking contexts as moderators of the relationship between neural markers of incentive salience and alcohol use behaviors.